Impact of Medical and Recreational Marijuana Laws On Cannabis, Opioids And Psychiatric Medications: National Study of VA Patients, 2000 - 2024

Thirty states now have medical marijuana laws (MML), 9 have recreational marijuana laws (RML), and many
more states are considering such laws. The health effects of cannabis laws are controversial; understanding
them is a major public health and NIDA priority (PA-17-135). Thus far, only 3 studies of adults (2 of them ours;
Hasin et al., 2017, Martins et al., 2016) used multi-level modeling to examine MML effects on cannabis outcomes
with individual data. These studies suggested post-MML increases in cannabis use and Cannabis Use Disorder
(CUD). However, they left many questions unanswered, including whether MML have stronger effects in those
with key vulnerability factors (chronic pain, psychiatric disorders). In addition, soaring rates of opioid prescriptions
and overdoses have led to calls for MML as part of the solution to the US opioid crisis, but most MML-opioid
studies are ecological (a weak design to study individual behavior), and results from individual-level studies leave
the evidence unclear. Ecological studies also suggest that through cannabis substitution, MML reduce
medication prescriptions for common psychiatric disorders (e.g., PTSD, depression), but no individual-level
studies of this have been conducted. Importantly, RML effects are almost entirely unknown, a major gap in
knowledge. In Veterans Administration (VA) patients, CUD prevalence has doubled since 2002, and in those
age ≥35, is 2-6 times higher than in the general population. VA patients also have high rates of opioid
prescriptions, overdoses, and of chronic pain and psychiatric disorders that may increase their vulnerability to
adverse MML and RML effects. They thus are a large, vulnerable population in whom MML and RML effects are
unknown. We will investigate MML and RML effects utilizing a major resource, the individual data from the VA
Electronic Medical Record, available since 2000 from the ~5,000,000 patients served each year by the VA
healthcare system. We will create yearly EMR datasets, and merge this with National Death Index data, Medicare
data (for those age ≥65) and state-year MML and RML variables that we will create. Using multi-level models
and difference-in-difference tests, we will examine MML and RML effects on three main outcomes: cannabis
(use, CUD), opioids (prescriptions, fatal and non-fatal overdoses, opioid use disorders), and psychotropic
medication prescriptions (antidepressants, anxiolytics, sedatives/hypnotics). Importantly, we will determine if
pain, psychiatric disorders or demographics (sex, age, race/ethnicity) modify MML/RML effects. We will also
examine specific MML/RML provisions, time lags, and breakpoints in trends reflecting federal policy changes.
Analyses will incorporate individual- and state-level confounders, e.g., state norms, economic factors. We will
also explore alcohol and tobacco outcomes. The research team includes substance epidemiology/policy experts
and VA addiction and internal medicine experts. Findings will be disseminated to clinicians and policy-makers.
Determining MML/RML effects in VA patients will make a major contribution to the limited adult literature on
MML/RML, contributing to knowledge that will inform policy and the care of individuals with vulnerability factors.

Public health relevance
U.S. medical marijuana laws (MML) and recreational marijuana laws (RML) are rapidly changing, but little is known about how these controversial laws affect populations with high rates of vulnerability factors, e.g., chronic pain, common psychiatric disorders (e.g., PTSD, depression). Veterans Administration (VA) patients are a large population with high rates of these vulnerability factors for whom an outstanding research resource exists: extensive electronic medical records (EMR) for over 5 million patients a year since 2000. We will analyze EMR data to determine MML and RML effects on cannabis (use and cannabis use disorder); opioids (prescriptions, fatal and non-fatal overdoses, opioid use disorders); and psychotropic medication prescriptions, providing important information on MML and RML effects in VA patients and in others with similar vulnerability factors to researchers, policy makers, health professionals and the public.